Understanding the dynamic interactions between tau pathology and microgliamediated inflammation in Alzheimer's Disease

Project Summary/Abstract
The etiology, mechanism and progression of Alzheimer’s Disease (AD), and the relationship of AD pathology
to clinical manifestations, are not fully understood. Emerging studies suggest that inflammation and microglial
activation is an important contributor to AD pathogenesis and progression. The association between tau and
microglia is especially critical, since tau is most closely associated with AD. The conventionally accepted
sequence of this interaction is that misfolded tau, which is pro-inflammatory, causes microglial activation,
leading to dendritic pruning and eventually neuronal cell death. However, it is recently emerging that microglial
activation can itself cause tau aggregation and subsequent propagation. Therefore the causality of these
interactions is controversial, and requires much needed elucidation in humans in vivo. The goal of this proposal
is to understand the interaction and causal sequencing between tau, neurodegeneration, microglia and
systemic inflammation in governing the etiology and progression of human AD. This proposal involves a series
of principled statistical and mathematical model-based tests that will uncover these relationships, for the first
time, directly in patients. This proposal involves a new prospective longitudinal study of 100 AD spectrum
patients acquiring brain MRI and PET imaging of activated microglia using a new generation TSPO ligand
called DPA-713 and tau-PET imaging using a relatively novel ligand, MK6240. The same imaging protocol
(MRI, DPA-713 and MK6240 PET) will be repeated at 18- and 36-month follow up time points. All subjects will
have amyloid neuritic plaque density measured at baseline using florbetaben PET. Next this proposal involves
developing and testing a model of microglial inflammation-tau interaction via mathematical models to
determine whether regional microglia-mediated neuroinflammation measured by DPA-PET is higher in AD
spectrum patients or in cognitively normal older adults; and whether regional microglial activation is predictable
directly from tau and/or amyloid. Finally, this proposed research includes testing a network spread model of tau
and microglia. Mounting animal data implicate a trans-neuronal transmission mechanism of tau through brain
networks. Using a network diffusion model of disease spread, this proposal will further investigate the role of
microglia in tau progression directly in humans. Since tau and microglia provide complementary signal about
evolving pathology, this proposal will determine whether combining imaging studies that measure both
biomarkers will result in a uniquely powerful and predictive test of AD progression. Given the rapidly evolving
understanding of the role of microglia and systemic inflammation in dementias, the current proposal is timely,
topical and necessary for advancing human dementia research. If successful, it will give the first validated
spatiotemporal model of the causal interactions between pathology and neuroinflammation in AD, catalyzing
future advances in prognostication and targeted anti-inflammatory therapies.

Public health relevance
Project Narrative Alzheimer’s Disease (AD) poses an increasingly large public health burden. By providing new insights into the role of neuroinflammation in AD, this study will provide the foundation for future advances in prognostication and targeted anti-inflammatory therapies for this devastating disease.